Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN)Scientific Leadership Center; ADMIN SUPPLEMENT

The scientific rationale for this supplement is to support the Adolescent Medicine Trials Network for HIV
Interventions (ATN) mission and overall aims. These supplemental funds are needed to cover unanticipated
costs that were not budgeted in either the original Scientific Leadership Center (SLC) application (RFA-HD-23-
020) or the Operations and Collaborations Center (OCC) application (RFA-HD-23-021) but are critical to the
successful execution of the ATN goals. All funds requested support core needs and gaps identified through
collaborative consultation with members of the SLC, OCC and NIH and are for activities that are within the
scope of the originally reviewed and awarded application. Based on our detailed review of the parent RFAs, we
anticipated that all of these activities would have been included in the application put forth by the OCC.
However, now that the network has launched, we have found that these critical gaps exist and re-budgeting
from the prime award to cover these costs is not an option because all the awarded funds are obligated.
Specific Aim 1: Advance a rigorous and innovative research agenda to end the HIV epidemic among
adolescents and young adults (ages 13-24) in the US by establishing a robust ATN infrastructure that
prioritizes and implements high-impact research. The administrative supplement will support research
gaps in current ATN agenda, specifically addressing HIV prevention and care needs among youth impacted by
alcohol use and aligning one of the currently supported protocols with a collaborative protocol in the HIV
Prevention Trials Network (HPTN). Further, the supplement supports important aspects of successful research
implementation, including enrollment and retention of participants through social media and eConsent and
critical aspects of monitoring participant safety and pharmacovigilance. Specific Aim 2: Facilitate internal
communication and external collaborations and idea exchange to optimize alignment with NIH
priorities, address emergent opportunities and maximize network productivity and resources. The
administrative supplement will support successful implementation and dissemination of ATN protocols. While
the OCC is developing the ATN website, they do not have the capacity or expertise to create any
recruitment/dissemination materials to be displayed on the website nor have they planned for any
dissemination activities at the site level. Specific Aim 3: Develop and nurture partnerships that will ensure
community and youth input at all stages of conceptualization, design, implementation, and
interpretation of the research. The administrative supplement will support adequate representation of youth
within the ATN. The Subject Matter Research Consultants (SMRC) are a core facet of the ATN and are being
deeply embedded into all aspects of the project including as members of protocol teams, scientific leadership
groups, and Communication and Dissemination Hub where they will provide ongoing consultation.

Public health relevance
The newly envisioned Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) is a multi- component collaborative research enterprise focused on the reduction of new HIV infections among adolescents and young adults in the US as well as improvements across the HIV continuum of care for youth living with HIV. The Scientific Leadership Center (SLC), led by Drs. Hightow-Weidman and Hosek, will bring all elements together and ensure that they function collaboratively, effectively, and efficiently with the Operations and Collaboration Center (OCC), NIH, and the overall network. Seven highly innovative and impactful clinical trials, led by talented multi-disciplinary teams that address all five ATN priority research areas, span key populations of youth, multiple socioecological systems, and a variety of regulatory phases are included.